Resource

PROJECT SUMMARY (Resource)
The Mutant Mouse Regional Resource Center (MMRRC) at the University of Missouri (MU) provides a unique
repository service by importing, storing and distributing mutant mouse strains, cryopreserved germplasm,
embryonic stem cells and related reagents, as well as performing research to continuously improve the use of
mouse models in research. Genetically engineered mice (GEM, i.e., transgenics, knock-outs and knock-ins)
are invaluable in biomedical research. Tens of thousands of GEM have been created over the last three
decades to facilitate better understanding of developmental biology and disease, and to test and improve the
function of drugs and therapeutics. Since the MMRRC network began, it has evolved into largest public mouse
resource for the research community with capabilities and a combined inventory of mouse lines and embryonic
stem (ES) cells that exceeds the capacity of other mouse repositories worldwide. The overall goal of this
proposal is to continue the existing services and expand the functions and capabilities of the MU MMRRC.
The specific aims are to 1) provide biomedical investigators with the mouse models and related reagents they
require for their research, 2) provide value-added services to aid the biomedical research community, and 3)
perform research that has broad application to all mouse models. Over the next five years, the MU MMRRC
will continue to rederive imported mice to a pathogen-free state; cryopreserve gametes and embryos; perform
genetic and infectious disease monitoring to ensure quality; and distribute live mice, cryopreserved germplasm,
tissues, and embryonic stem cells. Research efforts will continue to assess the role of complex gut microbiota
in model phenotypes and model reproducibility and translatability by producing mice with a defined and well
controlled humanized microbiota, and tools to better sample microbiota kinetics in living mice. These studies
will yield new paradigms by which the MMRRC can provide mice (i.e. harboring one or more humanized
complex microbiota) and refine value added services that will be made available to the biomedical research
community. The MU MMRRC will also continue offering an increasing number of services that generate
program income. Services include cryopreservation, cryoresuscitation from embryos or sperm, rederivation,
genotyping and assay development, genetic background complexity analysis, karyotyping, colony
management, phenotyping, and microbiome manipulation and analysis.